A New Molecular Target to Enhance Poststroke Cognitive Recovery

PROJECT SUMMARY
Stroke is a leading cause of long-term disability in U.S. and worldwide. Post-stroke cognitive impairment
(PSCI), a common sequela after stroke, is a decisive determinant of the quality of life for stroke survivors.
Clinical studies have indicated that PSCI is common in both young and old stroke patients, even in cases
of relative mild stroke and victims with successful thrombolysis and endovascular reperfusion therapies.
However, the underlying mechanisms of PSCI remains poorly understood and no FDA approved treatment
is available for PSCI. In this application, we propose to investigate the roles and therapeutic potential of
DKK3 in PSCI and the underlying mechanisms using an experimental stroke model of transient middle
cerebral artery occlusion (MCAO) followed by reperfusion. Previous studies (including ours) have
demonstrated that mice subjected to transient MCAO developed long-term cognitive deficits that correlate
with secondary damage to the hippocampus. Based on our promising pilot data, we hypothesize that DKK3
plays an important role not only in acute brain damage but also in secondary hippocampal damage and
thereby represents a novel promising therapeutic target for treating cognitive impairment after ischemic
stroke. First, we will determine the tempo-spatial regulation of DKK3 (and miR-125a) expression in the
normal and ischemic brains at different time points after stroke, and evaluate the efficacy of early treatment
versus delayed treatment by intranasal administration of recombinant DKK3 protein to ameliorate acute
stroke injury and to improve long-term neurologic and cognitive outcomes after ischemic stroke (Aim1).
Next, we will determine the mechanistic roles of DKK3 in neuropathology with the focus on the hippocampal
mechanisms of PSCI after ischemic stroke (Aim 2). To test this hypothesis, the loss-of-function and gain-
of-function experiments will be performed, in which conventional and conditional DKK3 knockout mice and
functional reconstitution study with recombinant DKK3 via intranasal drug delivery will be utilized. Based
on pilot data, we further hypothesize that ischemic stroke induces increase of miR-125a expression hence
down-regulates DKK3 expression in the hippocampus, which contributes to PSCI induced by transient
MCAO (Aim 3). We will determine the DKK3-dependent effects of miR-125a inhibition to improve PSCI
after ischemic stroke. Both young adult and aged mice will be studied. The proposed studies may reveal
previously unappreciated mechanisms underlying PSCI and provide a novel therapeutic approach to
improve neurologic and cognitive outcomes following ischemic stroke.

Public health relevance
PROJECT NARRATIVE Post-stroke cognitive impairment (PSCI) is a major sequela of stroke in both young and old stroke patients, with no FDA approved treatment. In this application, we propose to identify DKK3 as novel therapeutic target for the treatment of cognitive impairment induced by ischemic stroke. The proposed studies may reveal previously unappreciated mechanisms underlying PSCI and provide a novel therapeutic approach to improve cognitive outcomes following stroke.